Project 2: Synthetic Lethal Therapy for HPV-Negative Head and Neck Cancer

Summary
HPV-negative head and neck squamous cell carcinomas (HNSCC) typically lose G1/S cell cycle checkpoints,
with most tumors having mutations in TP53, and many also mutating other tumor suppressors such as CDKN2A.
Such tumors become dependent on checkpoints associated with G2/M to repair DNA damage arising from
replication stress and other genomic insults. This dependency suggests a tumor-selective vulnerability to
synthetic lethal strategies controlling progress through G2/M. In extensive preliminary data, we show that
AZD1775/adavosertib, an inhibitor of the G2/M checkpoint kinase WEE1, potently sensitizes TP53mut HNSCC
cell lines to inhibition of Aurora A kinase (AURKA). WEE1 induces an inhibitory Y15-phosphorylation of CDK1,
blocking M-phase entry and thus blunting the cytotoxic effects AURKA inhibition. WEE1 inhibition abrogates this
arrest, accelerating mitotic entry for cells bearing highly disruptive spindle abnormalities and other defects arising
from AURKA inhibition, resulting in mitotic catastrophe and apoptosis. We found combined AURKA/WEE1
inhibition is potent in HNSCC xenografts, while well-tolerated in normal tissue and cells. We have extended this
concept, identifying additional promising drug combinations between WEE1 and other G2/M regulatory kinases
(PLK1 and CHK1). Notably, the limited number of cells surviving synthetic lethal treatment are characterized by
aneuploidy and other defects suggesting they may have increased tumor mutation burden (TMB), express
neoantigens, and upregulated inflammatory signaling associated with sensitivity to immune checkpoint inhibition.
This project will take this observation directly to the clinic. We will conduct a pre-operative window phase I and
expansion clinical trial of the late generation, high potency selective AURKA inhibitor LY3295668 with
adavosertib combination, establishing pharmacodynamic proof of concept, identifying biomarkers for patient
selection in future studies, and placing synergistic combinations in context of genomic alteration and treatment
resistance. In Aim 1, we will evaluate mechanisms of combination lethality, and use single cell sequencing and
Luminex profiling to query TMB, predict neoantigens, and measure inflammatory signaling. Aim 2 will query the
effect of classes of common HNSCC TP53 and CDKN2A mutations, and cisplatin resistance, on response to a
WEE1-AURKA inhibitor combination, using defined cell line models and patient derived xenografts (PDXs). In
Aim 3, we will perform a pre-operative window trial to establish recommended phase 2 doses, determine activity
and establish pharmacodynamic proof of concept, and to evaluate putative predictive biomarkers for response
to combination WEE1/AURKA inhibition in HNSCC.

Public health relevance
Narrative Head and neck cancers often mutate TP53 and CDKN2A, reducing G1/S checkpoints; this leads to resistance to some treatments, but creates tumor-specific vulnerabilities to drugs targeting G2/M checkpoints. We identified three drug combinations for which simultaneous application of two drugs targeting G2/M was much more active than either drug alone, with a lead combination showing strong efficacy and no toxicity in a mouse xenograft model for head and neck cancer. The project will establish the mechanism of drug combination effectiveness, identify response biomarkers, determine how various complements of TP53 and CDKN2A mutations affect response, and perform a clinical trial to assess combination drug activity in head and neck tumors in humans.